Exposure to violence and maternal health

PROJECT SUMMARY
The number of women and children living in close proximity to armed conflict and/or community-based
violence has increased globally and in the United States in recent decades. Violence is known to disrupt health
service delivery and individuals’ ability to utilize certain health services, including antenatal care and facility
delivery. These disruptions likely contribute to poor maternal health outcomes, as well as disparities in
maternal and newborn mortality and morbidity. However, the limitations of existing data make it difficult to
identify the underlying mechanisms that shape these relationships, as well as how exposure to violence may
differentially affect maternal health outcomes among different sub-populations. The objective of this project is
to estimate how the precise location, timing, and intensity of community-based violence affect maternal health
outcomes, including whether and how exposure to violence contributes to disparities in maternal health.
This project draws on data from a three-year cluster-randomized controlled trial that began prior to the
onset of escalated community-based armed conflict in the study area. Combining household panel survey data
collected before and after the onset of violence, health facility records, and a dataset of violent conflict events
provides a unique opportunity to study the effects of community-based violence on maternal health with two
specific aims. In the first aim, we will analyze how differences in the precise location, timing, and intensity of
community-based violence affect the timing and quality of antenatal care and whether women deliver at a
health facility. In the second aim, we will test whether the relationship between exposure to violence and
maternal healthcare utilization outcomes varies by the location of violent events. Under this aim, we will draw
on health facility data to test whether exposure to violence near health facilities affects the uptake of maternal
healthcare services differentially from other types of healthcare services. For the analyses in both aims, we will
examine whether and how the relationship between exposure to violence and maternal healthcare utilization
outcomes varies by women’s socio-economic status and education.
Addressing maternal health disparities is a key challenge in population health in the United States and
globally, and a scientific priority. This research will enhance our understanding of the location-related
mechanisms through which exposure to violence shapes maternal healthcare utilization, and disparities in
maternal health outcomes; identify promising avenues for future research in this area; and generate rigorous
evidence for effective interventions to improve maternal health outcomes and equity among populations
affected by violence.

Public health relevance
PROJECT NARRATIVE This project seeks to assess how the location and timing of exposure to violence shape disparities in healthcare utilization among pregnant people. The results will allow maternal health programs and health systems to better address exposure to violence as a social determinant of maternal health disparities and healthcare utilization, and inform our understanding of the consequences of exposure to violence in the United States and globally.